MRI Metrics of Diastolic Dysfunction at Rest and Stress Validated by Estimated Pressures

Project Summary/Abstract
Heart failure with preserved ejection fraction (HFpEF) is characterized by a stiff heart which cannot fill
adequately with blood, without increasing filling (left atrial) pressure, which in turn results in
pulmonary congestion. Patients with HFpEF have unexplained breathlessness upon exercise. Its
hemodynamic correlate is elevated cardiac pressures. HFpEF is common, represents 50% of all HF,
and has similar mortality rates as HF with reduced ejection fraction (50% in five years). A major
challenge for HFpEF is that diagnosis by echocardiography is challenging, with many inconclusive
studies, and accuracy of about 68% to predict high pressures, with especially low sensitivity.
Therapies for HFpEF are lacking, and their development would be aided by better identification of
HFpEF. MRI is not able to diagnose HFpEF at all. To overcome these challenges, we propose to
develop MRI methods for diastolic function, including an approach to measuring tricuspid regurgitant
flow velocity, which is used to estimate pressures in the right heart, a key metric in diastolic function
evaluation. This method uses deep learning processing of long-axis cines to generate a dynamic
slice plane prescription, which is used in valve-tracking phase-contrast to measure tricuspid
regurgitant flow. This same technique, suitably modified can measure all or many of the diastolic
parameters (E, A, e' etc). To this end, we develop a valve-tracking PC approach which is carefully
tested in phantoms and human subjects, comparing regurgitation velocities by MRI vs. the standard.
We also develop methods for diastolic evaluation with 4D flow, including bSSFP 4D flow, with an
innovative approach. Then the importance of exercise is studied to unmask diastolic dysfunction. All
of these techniques are applied in patient cohorts where excellent ground truth data is available, first
in patients with correlative echocardiography and MRI (n=40), secondly in patients with implanted
pulmonary artery pressure sensors (n=20, imaged at two time points and using rest/stress, and thirdly
in patients with invasive right heart catheterization to measure all pressure data (n=40). We
hypothesize that MRI can measure TR pressure gradients accurately, and can detect changes in
diastolic parameters with exercise. We hypothesize that a single breath-held valve-tracking phase-
contrast acquisition could be used for diastolic evaluation of all needed parameters. We envision that
every cardiac MRI exam can employ a few additional breath-holds to fully evaluate diastolic function,
thus reaching its potential for diagnosis of HFpEF.

Public health relevance
Narrative To truly understand the value of MRI in guiding decisions about heart-failure with preserved ejection fraction, we will develop and test MRI methods similar to echocardiography in measuring elevated pressures in the heart. One method evaluates flow in leaky heart-valves (called regurgitation), using a constantly moving slice that zeros in on the heart-valve region. We develop a feasible method for evaluating the pressure in the heart, at rest and with exercises such as hand-grip, and determine their accuracy in patients, by comparing to the best available values (pressures obtained by catheterization).